DnaJB6 as a novel regulator of tau

Abstract
Alzheimer’s disease (AD) is a progressive neurodegenerative disease characterized by neuronal loss driven by
deposits of pathological tau. Therefore, identifying and targeting potent regulators of tau is crucial in developing
effective therapeutic strategies. My exciting preliminary data show DnaJB6 overexpression decreases tau
levels in HEK293T cells more than 50%, and in parallel, knockdown of DnaJB6 results in a 2-fold increase of
tau. This suggests that DnaJB6 may regulate tau levels, however, the nature of this relationship has not yet
been investigated. In this proposal, I will test the hypothesis that DnaJB6 can prevent tau accumulation through
direct and indirect mechanisms. In Aim 1, I will test this through assessing protein-protein interaction dynamics
between DnaJB6 and tau with recombinant in vitro assays, including Thioflavin T fluorescence and Surface
Plasmon Resonance. A targeted proteomic approach will be used to identify direct and proximal connections
between DnaJB6 and tau in primary neurons. In Aim 2, we will use PS19 and non-transgenic mice to assess
the associated behavioral and molecular changes that result from DnaJB6 overexpression in the brain.
Successful completion of these studies will provide crucial information regarding DnaJB6 biology, direct and
indirect effects of DnaJB6 on tau, and how regulation of DnaJB6 affects behavioral and molecular changes in
the tauopathic brain.

Public health relevance
Narrative The aberrant accumulation of tau is linked to neuronal loss and cognitive dysfunction in Alzheimer’s disease and other tauopathies. Based on our exciting preliminary data, I propose DnaJB6 as a potential target for mitigating tau pathology. Understanding more about the interactions between tau and DnaJB6 will provide fundamental knowledge that may be applicable to other DnaJ family members and additional aggregating proteins, which ultimately may aid in the development of novel therapeutics.